Impact of Opioid Withdrawal on SNl-TS Dopamine and Glutamate in Threat Learning

PROJECT SUMMARY
The opioid epidemic remains a critical public health crisis, marked by high rates of addiction, overdose, and
mortality. Opioid addiction is a chronic, relapsing disorder with withdrawal often triggering anxiety and avoidance,
leading to subsequent drug-seeking and taking behavior. This proposal aims to investigate the neural
mechanisms underlying opioid withdrawal-induced anxiety using a combination of behavioral animal models and
advanced neurotechnological techniques. Our experimental approach involves a model in which mice self-
administer oral oxycodone and display somatic withdrawal symptoms when oxycodone availability is removed.
My preliminary data show that mice will self-administer oral oxycodone and display withdrawal signs when
oxycodone availability is removed. Further, exposure to an innately threatening visual looming stimulus prompts
mice to engage in defensive behaviors, including avoidance. However, my recent work indicates that repeated
exposures to this looming stimulus leads to decreased avoidance behaviors, demonstrating that these defensive
behaviors are adaptive. Integrating these two models, my preliminary data show that mice undergoing opioid
forced abstinence exhibit impaired adaptive defensive responses, as evidenced by their persistent avoidance
behaviors toward the looming stimulus. The midbrain-striatal pathway utilizes dopamine and glutamate for
learning of rewarding and threatening stimuli and reinforces avoidance behaviors. The midbrain region,
substantial nigra pars lateralis (SNl) sends dopaminergic and glutamatergic projections to the tail of the striatum
(TS). Preliminary data indicate that dopamine and glutamate respond to threatening stimuli. Additionally,
dopamine release in the tail of the striatum (TS) initially responds to the visual looming stimulus and attenuates
with repeated exposures. During opioid abstinence, dopamine and glutamate response to threatening stimuli is
exaggerated, therefore, I hypothesize in opioid-abstinence disrupts dopamine and glutamate functioning in the
TS, leading to sustained avoidance behavior to the looming stimulus. A combination of fiber photometry,
optogenetics, and behavioral analyses of oxycodone intake and defensive behaviors will be used to target and
investigate the SNl-TS pathway. In Aim 1, we will evaluate opioid withdrawal-induced changes in dopamine and
glutamate release from SNl neurons to the TS. In Aim 2, we will manipulate dopamine, glutamate, and co-
transmission of dopamine-glutamate from the SNl to the TS during VLS presentations and identify changes in
defensive behaviors. The data generated from this project may identify novel mechanisms of neurotransmitter
transmissions that may reduce opioid withdrawal-induced anxiety.

Public health relevance
PROJECT NARRATIVE Withdrawal-induced anxiety from opioids poses a critical risk for drug relapse. The pathway from the substantia nigra pars lateralis (SNl) to the tail of the striatum (TS) is known for its role in threat learning relevant to anxiety behaviors. However, the implication of this pathway in the context of opioid withdrawal has not yet been explored. Our proposed experiments aim to uncover how specific cell types in the SNl-TS circuit contribute to the disruption of threat learning during opioid withdrawal.